Pediatric ECHORN Cohort Study: intergenerational factors that contribute to cardiovascular risk in the Eastern Caribbean

Project Summary
The epidemic of cardiovascular risk factors among racial/ethnic minority children will inevitably
worsen adult cardiovascular disease disparities. This proposal establishes a longitudinal
intergenerational cohort study in the Eastern Caribbean focused on furthering our understanding
of intergenerational factors contributing to cardiovascular risk, as well as the role of sleep
duration and quality. Being cognizant of the importance of parental perception of risk in
determining engagement in interventions targeting cardiovascular risk, we propose a mixed
methods study that will explore parental perceptions of childhood obesity. Additionally, we will
develop and operationalize a comprehensive portfolio of regionally-relevant structural/social
determinants of cardiovascular health utilizing participatory approaches. The ultimate goal of
this project is to identify individual and neighborhood level interventions that can curtail the
epidemic of cardiovascular disease in the region.

Public health relevance
Project Narrative The “Pediatric ECHORN Cohort Study: Intergenerational Factors that Contribute to Cardiovascular Risk in the Eastern Caribbean” will further our understanding of intergenerational factors that contribute to cardiovascular risk, as well as the role of sleep duration/quality on that risk.